Mechanisms of synaptic loss by the classical complement pathway in motor circuit development and disease

Project Summary/Abstract
This is an application for a diversity supplement according to FOA: Research Supplements to Promote
Diversity in Health-Related Research (PA-21-071) for Ms. Tatiana M. Gonzalez, a PhD student in my lab. Ms.
Gonzalez will be working on experiments for her PhD studies on the awarded and currently active R01 grant
(AA027079, entitled: “Mechanisms of synaptic loss by the classical complement pathway in motor circuit
development and disease”, PI: G.Z. Mentis).
The essence of this grant is to unravel the molecular and cellular mechanisms responsible for the
disruption of neuronal networks through synaptic elimination which leads to compromised motor output, both
during normal development and in the motor neuron disease, spinal muscular atrophy (SMA). These
mechanisms underlie the refinement of immature sensory-motor circuits during early normal development and
are the main cause for the severe phenotypic deficits in SMA. The Specific Aims of our currently active grant are
as follows: In Aim 1, we will determine whether aberrant activation of the classical complement pathway induces
loss of vulnerable synapses in SMA. In Aim 2, we will investigate the requirement of the classical complement
pathway for normal development of sensory-motor circuits. In Aim 3, we will determine the role of MEGF10 and
MERTK in mediating C1q and C3 (proteins of the classical complement) in tagging and eliminating sensory
synapses.
The studies that will be investigated by Ms. Tatiana Gonzalez, will involve aspects of Aim 2 and Aim 3.
Specifically, she will investigate to which extent supernumerary and inappropriate proprioceptive sensory
synapses are formed through C1q and C3 involvement. To address this, Ms. Gonzalez will utilize a novel
retrograde viral-mediated neuronal circuit tracing assay to selectively label and quantify hindlimb muscle-specific
sensory proprioceptive synapses on muscle-identified spinal motor neurons in mice at different developmental
ages. This assay relies on the expression of parvalbumin (PV) by proprioceptors; to prime fluorescent reporter
expression in the proprioceptors, a parvalbumin-directed FlpO recombinase (PV::FlpO) mouse line is crossed
with Cre- and Flp-dependent tdTomato reporter mice (Ai65). PV::FlpO;Ai65 neonatal mice will be injected
intramuscularly at birth with CAV2-CRE virus into the tibialis anterior (TA) to activate tdTomato expression in
proprioceptive sensory neurons innervating the TA. To label motor neurons innervating the antagonistic
Gastrocnemius (Gs) muscle, these mice will concomitantly be injected with scAAV6-GFP virus to express GFP
in Gs motor neurons. In this manner, proprioceptive TA fibers will be labelled with TdTomato (in red) and Gs
motor neurons with GFP (in green). Using immunohistochemistry and confocal microscopy, excitatory
glutamatergic proprioceptive sensory synapses will be labeled using an anti-VGluT1 antibody and the presence
of inappropriate synapses will be detected through the co-localization of VGluT1 with tdTomato on GFP+ Gs
motor neurons. With respect to Aim 3, Ms Gonzalez will investigate whether MEGF10 and MERTK are involved
in the excessive pruning of spinal synapses in SMA. To do so, she will use the appropriate knock out (KO) mouse
crosses as follows: she will generate MEGF10KO::SMA and MERTKKO::SMA mice and perform the righting time
behavioral assay to assess whether the SMA mice lacking MEGF10 or MERTK have any improved motor
function in comparison to regular SMA mice. She will perform physiological experiments on MEGF10KO::SMA
and MERTKKO::SMA mice using the ex vivo spinal cord preparation, to establish the amplitude of motor neuron
synaptic potentials and compared them to those from regular SMA mice and determine whether abolition of
MEGF10 or MERTK confers any functional benefit in SMA mice. Lastly, she will assess whether abolition of
MEGF10 and MERTK disrupts C1q and C3 tagging by utilizing immunohistochemistry and confocal microscopy.

Public health relevance
Project Narrative Neuronal control of movement is extensively studied not only because it underlies fundamental human behaviors but also because neurodegenerative diseases that affect the motor system represent a significant burden for human health. We have identified abnormalities in the way neurons communicated with each by means of abnormal removal of synaptic connections, which result in pathological situations. This proposal describes a multidisciplinary effort aimed to determine the molecular and cellular mechanisms that may contribute to human diseases such as spinal muscular atrophy—the leading genetic cause of death in infancy.